PATHS

Pathways for Authentic Teaching of Health Sciences (PATHS) is a five year project designed to build health literacy knowledge and skills. PATHS will provide teachers and students in rural, suburban, and urban Virginia communities with career awareness for the various educational trajectories and opportunities provided by health professions (Medical Lab Sciences, PT and OT, Radiation Science, and Dental Hygiene). PATHS will engage 60 secondary teachers (grades 7 through 12) over four years in a model program that provides curriculum and pedagogical support (professional development) reflecting best practices in science. Our aim is to support teachers and ultimately students in learning about the skills and content of health professions, the impact of social determinants of health (SDH), and to develop their ability to work with large data sets through medical tools related to precision health. The curriculum tools will be web-based modularized units to address five areas of health professions, SDH, and precision health and will provide content-rich and inquiry-based exposure to careers and skills necessary for health professions that are applicable to science, health/physical education, and career and technology education classrooms. Teachers will participate in two summer institutes with support during school-year follow-up sessions and virtual coaching. The project team along with the Virginia Area Health Education Centers (AHEC) will support teachers and their students with sharing their learning at Community Health Fairs, STEM Fairs, and other student research conferences.

Public health relevance
Providing the education community and students with knowledge of the various health professions and multiple ways to reach these professions is a critical need of public health. In addition, an understanding of the various social impacts on health (Social Determinants of Health) and use of data science tools modeled after Precision Health’s use of large data will inform teachers and students of how these tools may inform healthcare. PATHS will develop curriculum materials and deliver professional development designed to support teachers and their students and will provide an array of supports for community-engaged projects, such as health fairs.